Project RESIST: Increasing Resistance to Tobacco Marketing Among Young Adult Sexual Minority Women Using Inoculation Message Approaches

PROJECT SUMMARY. Young adult sexual minority women (SMW), including lesbians and bisexuals, are at
particularly high risk, with up to 4.8 times increased odds of cigarette smoking than heterosexual women; up to
660,000 young adult SMW smoke and are at increased risks of smoking-related cancers and cardiopulmonary
illnesses. Exposure to tobacco industry marketing, minority stressors, alcohol and drug use and social
determinants are key factors linked to increased smoking behavior in this population. Anti-smoking campaigns
utilized inoculation messages (analogous to vaccines) and culturally-tailoring (i.e., LGBT imagery, symbols,
and language) to promote resilience against tobacco marketing influences among LGBT audiences. However,
the effects of culturally tailored inoculation approaches in young adult SMW have not yet been examined. Our
long-term goal is to eliminate smoking-related health disparities among LGBT populations. The objectives of
this study are to determine the effects of using a culturally-tailored inoculation approach to increase resilience
to tobacco marketing influences among young adult SMW and obtain stakeholders' critical inputs that support
later adoption and implementation. Our central hypothesis is that culturally tailored inoculation messages
addressing unique perspectives of young adult SMW will be more effective versus non-tailored messages to
increase resilience to tobacco marketing. The scientific premise is supported by 1) campaigns promoting
resilience against tobacco companies and smoking among LGBT audiences, 2) our pilot study showing young
adult SMW perceive higher relevance, favorable attitudes, and positive emotions toward LGBT imagery
compared to control imagery, and 3) an integrative conceptual framework informed by communication science,
the minority stress framework, and the socioecological model of resilience factors among SMW. Our specific
aims are: 1) Engage with key stakeholders to optimize message construction and collect pilot data to inform
future intervention design, 2) Evaluate the effects of culturally tailored anti-smoking messages on young adult
SMW's smoking and quitting intentions, and 3) Evaluate the effects of inoculation message type, dose, and
latency on young adult SMW's resilience to tobacco marketing, smoking and quitting intentions. We will
conduct twice-yearly meetings, rapid cycle feedback, and key informant interviews with an Expert Advisory
Committee comprising LGBT organization leaders, investigators in sexual and gender minority health,
community members, and national agencies (NCI, CDC, and FDA); message development and testing using
qualitative research methods; and randomized survey experiments. Impact: Findings from this study will
provide the foundation to develop an evidence-based and culturally tailored inoculation approach to increase
resilience to tobacco marketing among young adult SMW and that addresses the needs of future adopters and
implementers. The study methods and findings will further inform research on counter-marketing interventions
to reduce smoking-related health disparities among all sexual and gender minority populations.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because young adult sexual minority women are disproportionately impacted by smoking-related health disparities, and research to identify effective and scalable counter-marketing approaches to reduce smoking among this priority population is limited. This research will be the first to determine the effects of inoculation with culturally-tailored counter-marketing messages to increase resistance to tobacco industry marketing, explore the impact of counter-marketing messages in relation to minority stress, resilience and social/environmental factors, and explore the mechanisms via emotions, beliefs and attitudes. This proposal directly addresses key scientific priorities in PAR-18-037 for research that leads to the development of acceptable and appropriate health interventions to ameliorate health disparities in SGM populations.